Localization of Secretion-Related Proteins in Pancreatic Islets of Langerhans

The protein IA-2, which is a member of the transmembrane protein tyrosine phosphatase family and a major autoantigen in type 1 diabetes, is found in dense-core vesicles (DCVs) of many neuroendocrine tissues. The luminal domain of IA-2 has a significant homology with the protein RESP18, which is also found in the lumen of the endoplasmic reticulum of neuroendocrine cells. Very little is known about the function of RESP18, but it has been hypothesized that the protein is implicated in the regulation of dense-core vesicle exocytosis in pancreatic islet cells. We have tested this hypothesis by localizing RESP18 using immunoelectron microscopy with anti-RESP18 polyclonal antibody, detected by colloidal gold conjugated to secondary antibody. We found that RESP18 is mainly expressed in the lumen of DCVs, and only to a lesser extent in the ER and Golgi network. Furthermore, double labeling experiments with 5-nm and 10-nm gold nanoparticles showed that RESP18 is co-localized with insulin in pancreatic beta cell vesicles, as well as with glucagon in pancreatic alpha cell vesicles.